NEUROCHEMICAL MARKERS--BRAIN BLOOD FLOW IN DEPRESSION AND BIPOLAR ILLNESS

Depressed patients may share trait and state markers of depression which will be corrected with antidepressant treatment and which may or may not revert to a pre-treatment state following cessation of treatment.